Decision support tool that uses novel feature extraction and machine learning approaches for early identification of Alzheimer's patients who are candidates for palliative and/or hospice care.

Nearly 6 million Americans had Alzheimer’s disease (AD) in 2019, a figure that will double by 2050. This
progressive disease can be difficult to manage at home for patients, and for their families and caregivers.
Timely and appropriate referral to palliative care can help. The medical literature suggests that as Alzheimer’s
progresses, palliative services can help improve quality of life and reduce the total cost of care (currently on
track to exceed $578 billion/year by 2050). Benefits include avoiding unnecessary hospitalizations, providing
support for in-home caregivers, and alleviating distressing symptoms. Despite these benefits, too few
Alzheimer’s sufferers are referred to palliative care services and, when they are referred, it is often too late.
Studies suggest that existing legacy tools do a poor job of timely identifying palliative care candidates among
AD patients. Even in cases where palliative care suitability is clear, medical professionals often lack the time
required or are uncomfortable discussing advance care planning. The aim of this research is to improve timely
and appropriate palliative care referrals for AD patients. We plan to develop and validate a novel clinical
application of cutting-edge machine learning techniques to identify AD patients for earlier palliative care
intervention. We will predict 12-month mortality as a proxy for palliative care appropriateness, building upon
previous research but also addressing its limitations. Our specific objectives are to (a) utilize six years of CMS
national Medicare claims data to generate the most detailed analysis to date of AD patient utilization history,
(b) develop a rich feature set of relevance to AD disease progression, encompassing medical utilization,
clinical, functional, socio-behavioral, and demographic dimensions, (c) train and evaluate an array of
supervised ML classifiers to predict 12-month mortality, and (d) develop a risk stratification score that may be
used clinically to rank-order AD patients in terms of their appropriateness for referral to palliative care. Our risk
stratification score will combine both the clinical appropriateness for palliative care (i.e., the need) and the
likelihood of a successful referral (i.e., the feasibility). The aforementioned “feasibility” element is especially
novel, and potentially represents a “missing link” that has hindered prior research. If our Phase I effort is
successful, the outcome will be a validated novel data-driven approach to risk-stratify AD patients for earlier
palliative care intervention. In a future Phase II proposal we would seek to demonstrate clinical efficacy by
productizing and deploying the risk stratifier into a real-time clinical decision support system and prospectively
evaluating this methodology in a clinical environment. Our proposal is responsive to the NIH/NIA’s mission “to
conduct research leading to the development of innovative products and/or services that may advance
progress in …caring for and treating AD/ADRD patients.” The planned work is specifically aligned with NIA
Priority Topic DBSR-C, which calls for innovations to support “evidence-based methods, technologies, and
interventions to reduce the burden of caregiving for persons with AD.”

Public health relevance
Given the immense economic and care quality impacts of Alzheimer’s disease, our health system is in need of a systematic and cost-effective approach to meeting the dynamic care needs of Alzheimer’s patients, particularly in later stages of the disease. The medical literature suggests that appropriate timing and intensity of palliative services could meet this urgent public health need, complementing other ongoing efforts to alter the clinical course of Alzheimer’s through disease-directed therapy. Our proposal develops and validates a novel data-driven approach to help ensure that more of the right Alzheimer’s patients are referred to palliative care services at the right time, thereby improving quality of life for Alzheimer’s patients and contributing to the solvency of Medicare.